Selenium at the intersection of glucocorticoids and metabolic disorder

Glucocorticoids (GCs) are commonly prescribed in humans for their anti-inflammatory and
immunosuppressive properties, but long-term consumption can cause metabolic side-effects, such as
overeating, excess weight gain, and glucose imbalance. Past work suggests an interaction between
GCs and the essential trace element selenium (Se). Work in mouse models has shown that Se-based
therapy can alleviate the neurological symptoms of stress and exogenous corticosterone (CORT)
administration. Conversely, CORT has been shown to affect selenoprotein expression in several
different tissues and cell types. To date, there has not been a comprehensive study on the effects of
CORT on Se homeostasis throughout the body. Preliminary data has shown altered selenoprotein
levels in tissues from mice administered CORT for 4-6 weeks, including elevated Selenoprotein P
(SELENOP) in blood and liver. SELENOP delivers dietary Se throughout the body, and has also been
proposed to play a role in the development of metabolic disorders. This project will determine the
impact of long-term CORT consumption on Se homeostasis throughout the body, as well as the role of
SELENOP in CORT-induced metabolic disturbances. The central hypothesis is that CORT-induced
dys-homeostasis of Se and selenoprotein levels lead to metabolic impairments. This hypothesis will be
investigated through the following specific aims: Specific Aim 1: Determine if CORT disrupts the
distribution of Se throughout the body. Hypothesis: CORT will increase Se content in certain tissues
that rely on SELENOP while decreasing Se in other tissues. Specific Aim 2: Determine if SELENOP
mediates CORT-induced metabolic dysfunction. Hypothesis: Elevated SELENOP promotes weight gain
in mice through actions in the hypothalamus and brown adipose tissue. Mice will be administered
CORT via drinking water and will undergo comprehensive metabolic phenotyping, including the use of
metabolic cages and implantable temperature probes. Tissues will be analyzed for Se content using
total reflection x-ray fluorescence (TXRF) spectrometry. Additionally, markers of cellular stress and
dysfunction will be assayed in brown adipose tissue, pancreas and hypothalamus. We predict that our
results will provide important insights on the interactions between GCs and Se, and their impact on
energy homeostasis.